EFFICACY STUDY OF IRBESARTAN IN HYPERTENSIVE TYPE II DIABETICS

The purpose of this study is to evaluate the safety and effectiveness of irbesartan on kidney function and blood pressure in individuals with kidney damage due to Type II diabetes.